Anatomy of the Primate Amygdaloid Complex

DESCRIPTION (provided by applicant): The primate amygdala is a complex brain region comprised of 13 nuclei and cortical regions in the rostral portion of the medial temporal lobe. This grant has funded studies with the overarching goal of defining the cytoarchitectonic organization and intrinsic and extrinsic connections of the macaque monkey amygdaloid complex. We have also been investigating neuropathology in the autistic amygdala. We reported that the amygdala in typically developing boys undergoes a 40% increase in volume between 7 and 18 years of age. This expansion occurs at a time when the cerebral volume decreases by about 10%. In boys with autism, the amygdala reaches its adult size by 7 years and does not increase thereafter. Given the association of the amygdala with a variety of psychiatric disorders including anxiety, depression, autism and schizophrenia, many of which are first manifest during the peripubertal period, it would be valuable to determine the morphological features of the amygdala's postnatal development. It is not feasible, however, to carry out this type of analysis in postmortem human brains. Thus, with this renewal we will begin studies to investigate the postnatal development of the macaque amygdala. First, we will carry out a longitudinal magnetic resonance imaging study of the brains of developing male and female rhesus monkeys to determine whether the dramatic and disproportionate growth of the amygdala in boys is also a feature of macaque development. Second, we will quantitatively analyze the emergence of species typical behaviors in the imaged animals.Third, we will implement modern design-based stereological techniques to measure the volume, count neuron number, and characterize neuron morphology in the amygdala throughout postnatal development. Fourth, we will use histochemical and immunohistochemical techniques to characterize the postnatal development of four major neurotransmitter systems (i.e., glutamatergic, GABAergic, cholinergic and serotonergic) in the amygdala. In addition, we will investigate the development of myelination and the expression of non-phosphorylated neurofilaments and synaptic markers (synaptophysin). Finally, we will use the Golgi technique and intracellular labeling of neurons in the in vitro slice preparation to quantify the maturation of dendrites in the major nuclei of the amygdaloid complex. This work provides essential normative data to study influences like circulating hormones or social experience on amygdala maturation.